PROJECT 3 – BIOLOGY OF DNA DEAMINASES IN CANCER

PROJECT 3 – BIOLOGY OF DNA DEAMINASES IN CANCER
ABSTRACT
APOBEC3 (A3) enzymes are a major cause of genomic mutation in many different cancers. A3s are single-
stranded (ss)DNA cytosine to uracil (C-to-U) deaminases that function normally in innate antiviral immunity, but
they often become expressed aberrantly in cancer and promote DNA damage, mutagenesis, and genome
instability. Work in the original funding period has converged on APOBEC3A (A3A) and APOBEC3B (A3B) as
the main etiologic agents. However, major gaps remain in understanding how these two enzymes become
dysregulated in tumor cells and contribute to driving tumor progression and poor clinical outcomes. To address
these gaps and to test our Program’s overarching hypothesis that disabling A3A/B activity will slow tumor
evolution, we are pursuing two comprehensive specific aims. Aim 1 studies are focused on investigating A3A/B
regulation at the protein level (upstream of ssDNA deamination). Several complementary approaches including
genetics, proteomics, and informatics will be used to understand the molecular mechanisms of A3A/B regulation
in normal and tumor cells. Aim 2 studies are focused on investigating the proteins and pathways that compete
for uracil lesion processing and ultimately elaborate the different mutational outcomes that are observed
(downstream of ssDNA deamination). Aim 2 studies will leverage human cellular systems as well as novel murine
models for A3A/B mutagenesis, where these enzymes are individually capable of driving tumor formation.
Importantly, Aim 2 studies will also utilize cellular and in vivo systems to assess candidate A3A/B inhibitors from
the combined efforts of this Program and ultimately test our central hypothesis that tumor evolution can be slowed
to prevent detrimental outcomes.

Public health relevance
PROJECT 3 – BIOLOGY OF DNA DEAMINASES IN CANCER NARRATIVE A major endogenous source of mutation has emerged with the discovery of APOBEC enzyme-catalyzed mutagenesis in a majority of human cancers. Project 3 studies will yield key insights into protein-level regulatory processes and downstream DNA repair pathways. The mechanistic information and technologies produced from these studies will expedite Program efforts to develop methods to stop this mutational process in cancer and thereby prevent lethal clinical outcomes including drug resistance and metastasis.